Tissue-Resident Adaptive CD56bright NK Cell Responses in Cancer

ABSTRACT
Natural killer (NK) cells are key mediators of anti-tumor immune responses, acting to directly kill cancer cells
(CD56dim subtype) and recruit pro-inflammatory immune populations (CD56bright subtype). Recent discoveries,
however, have revealed other NK cell subtypes with properties of tissue-resident and adaptive, memory-like
phenotypes. Tissue-resident NK cells have been shown to have elevated production of chemokines, such as
CCL3 and XCL1 that, in turn, recruit conventional type 1 dendritic cells (cDC1) and CD8+ T cells to tumors.
Adaptive NK cells have been shown to persist for months longer than conventional NK cells and display
enhanced tumor cell killing. Given the diversity of the NK cell repertoire, it is crucial to identify which NK cell
subtypes exist in tumors and are key to anti-tumor responses. To address this, our group has generated a pan-
cancer atlas of NK cells using single-cell RNA-sequencing data from 326 patients across 17 cancer types. In
doing so, we identified prominent populations of CD56bright NK cells that display gene signatures suggestive of
both tissue-resident and adaptive NK phenotypes (bright-taNKs). We found bright-taNKs to display higher
expression of chemokines and cytokines, such as CCL3, XCL1, and IFNG, suggesting a functional role in
immune cell recruitment to tumors. Using a gene signature to estimate the relative abundance of bright-taNKs
in bulk RNA-seq data, we found that bright-taNKs are associated with significantly longer disease-free survival
in cancer patients. Thus, bright-taNKs may be critical for anti-tumor immunity and represent attractive
phenotypes to mimic for the next generation of engineered NK cell therapies. As little is currently known about
bright-taNKs, this proposal aims to advance our understanding of the functions of bright-taNKs in tumors and
identify mechanisms promoting their distinct phenotypes. In Aim 1, we will use orthogonal methods to determine
whether bright-taNK populations are associated with increased recruitment of anti-tumor immune populations,
such as cDC1s and CD8+ T cells. We will develop a bioinformatics tool that can be paired with well-established
tools to estimate fractions of different NK cell subtypes and other immune cell types in bulk RNA-seq data.
Additionally, we will apply highly-multiplexed spatial imaging tools to interrogate the spatial distribution of bright-
taNKs, and other NK cell populations, in tumors and their associations with other immune cell types. In Aim 2,
we will use gene delivery platforms to screen for transcription factors that promote features of tissue-resident
and adaptive phenotypes in CD56bright NK cells. We will then transition the most promising gene targets to our
clinical-grade induced pluripotent stem cell to NK cell (iNK) platform to holistically evaluate the effects on anti-
tumor functions. Altogether, this proposal aims to advance our understanding of bright-taNKs, and other NK cell
subtypes, in tumors. Ultimately, drivers of favorable NK cell properties can be readily integrated into our group’s
bench-to-bedside pipeline for NK cell therapies to enhance their efficacy and durability.

Public health relevance
PROJECT NARRATIVE Natural killer (NK) cells are pivotal in the immune response against cancer, acting to directly eliminate cancer cells and recruit other anti-tumor immune populations. This proposal focuses on advancing our understanding of a unique NK cell subtype with enhanced abilities to recruit anti-tumor immune responders, and infiltrate and survive in suppressive tumor environments. Insights gained from this study will contribute to new tools for studying diverse NK cell subtypes and inform the development of NK cell-based therapies for combating cancer.